Examining the impact of endogenous CD28 signaling on CAR T cells

Project Abstract/Summary.
Recent advances in immune cell engineering have revolutionized the treatment of blood cancers. Genetic
modification of T cells, whose physiological job is to kill infected and mutant cells throughout our bodies, with
Chimeric Antigen Receptors (CARs) can redirect T cell killing activity against malignant cells that express certain
target proteins on their surface. CARs are built to mimic physiological T cell signaling, which is unique in its
requirement for two signals provided by the T cell receptor (TCR) and co-receptors, such as CD28, to induce T
cell function. Recent clinical studies in multiple myeloma (MM), a common incurable blood cancer, have shown
that CAR T cells are remarkably effective at treating patients who do not respond to standard of care
chemotherapies. Despite this, most MM patients relapsed within a year of CAR T cell therapy and the cause of
their relapses was not readily apparent. The long-term goal of the project proposed in this grant application is to
use our knowledge or T cell signaling to make CAR T cell therapy for MM more effective. To this end, we have
found that endogenous CD28 on CAR T cells disrupts their ability to kill MM cells that express CD28 stimulatory
proteins CD80 and CD86. However, the same endogenous CD28 is essential for making CAR T cells and we
have also found that the CD28 signal provided during the CAR T cell manufacturing process helps determine
how good of tumor killers CAR T cells become. Proposed studies seek to 1) identify ways to manipulate CD28
signaling during CAR T cell manufacture that can improve their long-term ability to kill MM cells in patients, and
2) determine how endogenous CD28 signaling causes dysfunction of CAR T cells. Results of these studies will
have direct clinical implications because adjustments to the CAR T cell manufacturing process could be rapidly
implemented and a drug that blocks CD28 activation, abatacept, is already used to treat people suffering from
rheumatoid arthritis.

Public health relevance
Project Narrative. Proposed research will contribute to fundamental understanding of signaling in Chimeric Antigen Receptor (CAR) modified T cells, a recently approved biological therapeutic for the treatment of B cell malignancies. Specifically, studies will determine how CAR T cells are regulated by the endogenous T cell co-stimulatory receptor CD28 found on their surface. New knowledge gained from completion of proposed studies will have direct clinical implications as there is an FDA approved agent used to treat rheumatoid arthritis, abatacept, that could be repurposed to block CD28 signaling in cancer patients undergoing CAR T cell adoptive immunotherapy.